Immune Responses to Malaria, HIV and SARS-CoV-2 Infection and Immunization

ABSTRACT (Overall)
Malaria, HIV/AIDS, and Covid are three of the most devastating infectious diseases, impacting millions of people
world-wide. Effective vaccines against the pathogens that cause these diseases (HIV, SARS-CoV-2 and
Plasmodium falciparum) have proven elusive and/or affected by pathogen variation and thus traditional vaccine
approaches are unlikely to succeed in eradicating these diseases. In addition to our limited understanding of the
desired immune responses to confer protection against the pathogens and our limited ability to elicit such
responses, vaccine efficacy is also confounded by the diversity of pathogens, human populations, environmental
exposures, and health status. The projects described herein are designed to support the identification of immune
profiles that correlate with vaccine efficacy and are of potential relevance to protection against HIV-1, SARS
CoV-2 and P. falciparum infection. Beyond the importance of combatting these diseases, the strategies for
profiling immunity in response to infection and vaccination hold promise for garnering fundamental insights into
the complexity of the human immune system. Such insights have the potential to impact strategies for vaccine
development and for producing new therapies for many diseases.

Public health relevance
NARRATIVE (Overall) This project is investigating the human immune responses to infection by and vaccination against three of the most prevalent and devastating global diseases, malaria, HIV-AIDS, and Covid. It is doing so to elucidate detailed characteristics of these immune responses to aid development of needed vaccines and therapeutics.